Role of TEMs in brain tumor dispersal

DESCRIPTION (provided by applicant): The ability of therapeutic agents to inhibit glioma growth is drastically limited by the development of resistance. Currently, clinical trials using anti-angiogenesis therapies are showing encouraging results. However, clinical practice reveals that cancer patients initially responding to angiogenesis inhibitors their tumors elicit an evasive resistance. Pre-clinical and clinical data further implicate angiogenesis inhibition as a driving force in tumor progression to stages of greater malignancy, reflected in heightened invasion and tumor dispersal into surrounding tissue. The molecular and cellular events underlying the invasion-based tumor recurrence are incompletely understood, and further preclinical studies should be warranted to elucidate the mechanisms of this adaptive-evasive resistance, so as to design and test the potential of mechanism-based combination therapies aimed at impeding this insidious consequence of singular antiangiogenic therapy. Our preliminary data show that, following anti-VEGF treatment, the tumors acquired a new phenotype that was characterized by migration, infiltration and aggregations of glioma cells far from the original tumor mass. In addition, we observed a dramatic accumulation of Tie2+ monocytes (TEMs) in the tumor areas undergoing extracellular matrix remodeling. Co-cultures of glioma cells and TEMs showed increased migration and invasion capabilities in vitro. In addition we have set up a novel physiologically-relevant human biomatrix culture system to examine the invasion of glioma cells when co-cultured with TEMs in 3D conditions. We have also established a transgenic animal model to unequivocally determine the role of the stroma in tumor invasion. These findings suggest that recurrence after anti-VEGF treatment is determined by the ability of tumors to prime and recruit TEMs. To test our hypothesis and achieve the objectives of this project we propose the following Aims: Specific Aim 1: Determine the effects of anti-VEGF therapy on host cell infiltrates in intracranial xenografts. Specific Aim 2: Analyze the phenotype and functional characteristics of Tie2 expressing monocytes in tumors refractory to anti-VEGF therapies. Specific Aim3: Examine in vivo the role of TEMs in the tumor refractoriness to anti-angiogenesis treatment. This work is highly focused on establishing a functional mechanistic link between TEMs and tumor dispersal in brain tumors treated with anti-VEGF therapies. Because the recurrence of tumors treated with anti-VEGF therapies is characterized by heighten invasion, stroma cell-intrinsic or treatment-induced expression of pro-invasion factors during tumor progression causing tumor dispersal might be implicated. Identifying the tight control of invasion by stroma cells should provide new therapeutic avenues as tumor stroma is considered an emerging target for cancer therapy.

Public health relevance
PUBLIC HEALTH RELEVANCE: Anti-angiogenesis drugs are among the most promising agents to treat brain tumors; however, potent angiogenesis inhibition alters the natural history of tumors by increasing invasion and promoting tumor dispersal. We believe that interactions of glioma cells with monocyte-infiltrating tumors expressing a key cellular receptor termed Tie2 are the basis for the heightened invasiveness. Results obtained from this proposal should propel the development of new therapies combining the targeting of vascular structures in the tumor and the Tie2+ monocytes and, as a result, improve the effect of anti-angiogenesis therapies and the prognosis of malignant brain tumors. PROJECT NARRATIVE Anti-angiogenesis drugs are among the most promising agents to treat brain tumors; however, potent angiogenesis inhibition alters the natural history of tumors by increasing invasion and promoting tumor dispersal. We believe that interactions of glioma cells with monocyte-infiltrating tumors expressing a key cellular receptor termed Tie2 are the basis for the heightened invasiveness. Results obtained from this proposal should propel the development of new therapies combining the targeting of vascular structures in the tumor and the Tie2+ monocytes and, as a result, improve the effect of anti-angiogenesis therapies and the prognosis of malignant brain tumors. __SpecificAimsTextDelimiter__ SPECIFIC AIMS The clinical approach of using antibodies that sequester molecules in the bloodstream is an elegant solution to the drug-uptake problem in neuro-oncology. Encouraging results from clinical trials using the humanized anti-vascular endothelial growth factor (VEGF) antibody bevacizumab indicated increased patient response rates. However, the observed benefit is no more than temporary, suggesting the emergence of a resistant phenotype. Our group recently reported, using a animal model for intracranial gliomas, that VEGF Trap/aflibercept, a soluble decoy receptor for VEGF, exhibited anticancer effect (1). These studies constituted the basis of a clinical trial that is currently recruiting patients. We showed that VEGF Trap treatment was efficacious in both initial and advanced phases of tumor development. Importantly, treatment with VEGF Trap resulted in a shift in the pattern of tumor growth. The new phenotype was characterized by migration, infiltration and aggregations of glioma cells in the perivascular regions, far from the original tumor mass, suggesting that the therapy has prompted the acquisition of an invasive phenotype. These results agree with data glioblastoma patients treated with the anti-angiogenesis drug bevacizumab showing the development of invasive and multifocal recurrence (2, 3). Therefore data from the literature and from our laboratory indicate that the development of an infiltrative/invasive phenotype may be the cause of the recurrence of tumors treated with anti-angiogenesis drugs. The mechanisms underlying this key feature of the recurrence are still unknown. Work from our laboratory shows that Tie2-expressing monocytes (TEMs) are highly frequent in the tumor/normal brain edge in animals treated with anti-VEGF therapies that display a heightened invasion. In addition, we observed a dramatic accumulation of Tie2+ monocytes (TEMs) in the tumor areas undergoing extracellular matrix remodeling. Co-cultures of glioma cells and TEMs showed increased migration and invasion capabilities in vitro. In addition we have set up a novel physiologically- relevant human biomatrix culture system to examine the invasion of glioma cells when co-cultured with TEMs in 3D conditions. We have also established a transgenic animal model to unequivocally determine the role of the stroma in tumor invasion. These findings suggest that recurrence after anti- VEGF treatment is determined by the ability of tumors to prime and recruit TEMs. Based on our preliminary data in this proposal we hypothesize that TEMs are responsible for the aggressive infiltrative phenotype observed in malignant gliomas that recur after anti-angiogenesis therapies. A corollary of this hypothesis is that depletion of TEMs will rescue the invasive phenotype emerging upon anti-VEGF therapies. To test our hypothesis and achieve the objective of this application we propose the following thee specific aims: Specific Aim 1: Determine the effects of anti-VEGF therapy on host cell infiltrates in intracranial xenografts. We will achieve the characterization of tumor models (human glioma xenografts, brain tumor stem cells (BTSCs), syngenic murine tumors) for the response of tumors to anti-VEGF therapies. We expect to demonstrate that the highly invasive phenotype is a specific response to anti- angiogenesis therapies. We also aim to establish the correlation between accumulation of TEMs and development of the pro-invasive phenotype Specific Aim 2: Analyze the phenotype and functional characteristics of Tie2-expressing monocytes in tumors refractory to anti-VEGF therapies. We will demonstrate that Tie2-expressing monocytes enhance invasion of glioma cells using co-cultures and 3D structures. Moreover, we will identify the molecular players expressed by the TEMs that mediate the brain tumor dispersal. Specific Aim 3: Examine in vivo the role of TEMs in the tumor refractoriness to anti- angiogenesis therapies. We shall demonstrate that modulation of TEMs using chemical methods or specifically engineered transgenic animal models, or co-implanting TEMs together with glioma cells, will modify the capability of glioma cells to acquire an invasive phenotype after anti-VEGF therapy. Moreover, we will test the effect of combining anti-TEMs and anti-VEGF therapy to diminish recurrence, resulting in long-term survivors. Tumor dispersion is the reason for gliomas to escape to current therapies, to recur and to remain one of the deadliest tumors. We aim to show that the interaction of cancer cells with the stroma is responsible for the enhanced tumor invasiveness after anti-angiogenesis therapies and therefore that components of the stroma should be included as key targets for the development of novel therapies for brain tumors.